Multiscale Computational Microscopy of HIV-1

ABSTRACT
The human immunodeficiency virus 1 (HIV-1) is the RNA retrovirus that causes acquired
immunodeficiency syndrome (AIDS), a disease that has killed over 40 million people worldwide
and infected more than twice that. Continued high infection rates has made understanding of
HIV biology and vaccines a high priority. A key molecule involved in both infection and vaccine
efforts is the HIV-1 Envelope protein (Env). Experimental structural biology techniques have
characterized the basic structure of Env, but they are unable to provide details about the
extensive N-linked glycan shield nor inform on the flexibility and dynamics of Env. In this
proposal, we envision using all-atom molecular dynamics simulations as a `computational
microscope,' to provide insights into the dynamics of Env that are unattainable with current
experimental techniques. Together with top flight experimentalists, we will develop and simulate
a series of models to explore the dynamics of Env as well as its interactions with co-receptors
and the cell glycocalyx, in unprecedented detail. In addition, we will use advanced simulation
techniques to optimize immunogen design as well as provide critical information about hitherto
unseen druggable sites in Env.

Public health relevance
NARRATIVE We will use multiscale all-atom molecular dynamics simulations as a `computational microscope,' to provide insights into the dynamics of the HIV-1 envelope protein (Env) that are unattainable with current experimental techniques. Together with top flight experimentalists, we will develop and simulate a series of models to explore the dynamics of Env as well as its interactions with its receptor, co-receptors and the cell glycocalyx, under physiological conditions. In addition, we will use advanced simulation techniques to optimize immunogen design as well as provide critical information about hitherto unseen therapeutic vulnerabilities in Env.